Biosynthesis of Unusual Bio-Orthogonal Functionalities in Natural Products

SUMMARY
Natural products are important small molecules for studying, treating, and even causing human diseases, and
they typically have unique functional groups that are critical for their biological activities. By exploiting the
biosynthetic machinery by which these functionalities are synthesized, it is possible to enhance, vary or diminish
the biological activities of parent compounds and apply the biosynthetic machinery to new systems for functional
group installation. Toward this goal, the chemical logic and enzymatic machinery underlying natural product
biosynthesis need to be fully characterized and understood. Our lab has been focused on the biosynthesis of
unusual pharmacophores of natural products, including but not limited to terminal alkene, alkyne, isonitrile, and
N-hydroxytriazene. These moieties often serve as the warhead of bioactive NPs and have distinct physical
properties that enable molecular tracking such as Raman- or IR-imaging based cellular uptake and dynamic
studies. More importantly, they are often called “clickable” and utilized in bio-orthogonal chemical transformations
for various chemical biology applications. Specifically, our program has and will continue to make contributions
in the following four areas: 1) Novel enzyme discovery. “Bio-orthogonal” suggests that these functionalities are
rare in nature, but structures of a few rare NPs have already indicated the prospect of novel enzyme discovery
for these functionalities. 2) Enzyme mechanism interrogation. New and fundamental insights into the catalytic
mechanisms of these new enzymes will be obtained. 3) Biocatalysis and biosynthetic pathway engineering. We
plan to examine the substrate scope of new enzymes in detail and explore the utilization of these biosynthetic
machinery to install “clickable” functionalities on various biomolecules on demand. 4) Leveraging the unique
properties of these functionalities to promote natural product research, such as visualization, identification,
enrichment, quantification, diversification, and biological target identification. Our program employs
multidisciplinary approaches including bioinformatics, genetics, heterologous reconstitution, organic synthesis,
biochemical and structural analysis, spectroscopic analysis, bio-orthogonal chemistry, protein engineering, and
pathway engineering, with support from world-renowned collaborators providing complementary expertise in
structural biology, bioinorganic chemistry, computational chemistry, enzymology, chemical biology, biophysics,
and microbiology.

Public health relevance
Public Health Relevance Statement: The proposed research is relevant to public health because it studies the biosynthetic mechanisms of unique functionalities in natural products that serve as biological warheads and are also useful for numerous chemical biology applications. A detailed mechanistic understanding is thus of both biomedical and biotechnological importance to target or adapt these biosynthetic pathways in a wide endeavor to promote human health.